RFA-IP-22-004, Multidisciplinary Approach to Understanding Vaccine Efficacy and Transmission of Viral Respiratory Tract Infections in the Real World

PROJECT SUMMARY/ABSTRACT – COMPONENT A
Influenza and SARS-CoV-2 are major causes of morbidity and mortality and constitute the leading
causes of vaccine preventable deaths in the United States. A better understanding of vaccine
effectiveness for these viral pathogens is critical to drive public health decisions and interventions. We
propose utilizing a multidisciplinary approach to conduct a test-negative study to determine influenza
and SARS-CoV-2 vaccine effectiveness in ambulatory patients with respiratory tract infections. The
team of investigators includes experts in emergency medicine, infectious disease, pediatrics,
epidemiology, information technology, molecular microbiology, virology, and genetics. This team has
extensive experience in automated electronic medical record alerts, high-volume subject recruitment
of ambulatory patients with respiratory tract infections, rapid escalation/de-escalation of recruitment
efforts to match viral circulation patterns, respiratory and blood sample processing and shipment,
quality data collection and verification, and viral genomic sequencing necessary to ensure the success
of this project. The proposed study will encompass the following specific aims: 1)Utilize innovative
automated alerting strategies to identify and recruit a diverse population of ambulatory patients with
acute respiratory illnesses; 2) Estimate influenza and SARS-CoV-2 vaccine effectiveness using a test-
negative study design in the general population as well as different demographic subgroups.; 3) Explore
factors that influence influenza and SARS-CoV-2 vaccine effectiveness such as co-morbidities,
vaccination type and schedule, and social determinants of health; 4) Determine effect of viral
vaccination status on health outcomes in ambulatory patients with influenza and SARS-CoV-2 infection;
5) Contribute biospecimens and viral genomic sequencing data to a national repository of subjects with
PCR-confirmed influenza or SARS-CoV-2 infection. To accomplish these goals, we will enroll at least
1000 ambulatory patients/year with acute respiratory tract infections in the proposed study. The subject
population will be identified from the emergency departments of 3 large hospitals in the St. Louis area
and their associated outpatient clinics. The available patient population at these enrolling sites is
diverse with respect to race, ethnicity, age, socioeconomic status, and medical care access which will
enhance the generalizability of the study outcomes to the US population.

Public health relevance
PROJECT NARRATIVE – COMPONENT A Influenza and SARS-CoV-2 infections are the leading causes of vaccine preventable deaths in the United States. Yearly changes in influenza vaccines as well as the creation of new vaccines for SARS- CoV-2 make it imperative to understand what factors affect respiratory viral vaccine effectiveness. This study proposes to utilize a test negative study design to determine the real-world effectiveness of influenza and SARS-CoV-2 vaccines in different populations and the factors that alter their effectiveness. PROJECT NARRATIVE – COMPONENT C The factors which influence the observed variability in influenza and SARS-CoV-2 transmission in households is poorly understood. This study is a case-ascertained household transmission study to determine what patient and environmental factors affect influenza and SARS-CoV-2 transmission within the home. The role of viral vaccination on household transmission will also be explored. PROJECT NARRATIVE – COMPONENT D Understanding the human immune response to viral vaccination is critical to the development of more effective viral vaccines. This study will enroll participants for a prospective study of the immune response to influenza and SARS-CoV-2 vaccination. This study will contribute data and samples to a national consortium to elucidate the immune response within 4 weeks of influenza and SARS-CoV-2 vaccination to inform future improvement in available respiratory viral vaccines and vaccine strategy.